Natural language processing and medical imaging analysis for multi-modality computer assisted diagnosis of ophthalmic diseases

PROJECT ABSTRACT
No change since original proposal

Public health relevance
The proposed research is relevant to public health because it involves new strategies to develop accurate and generalized computer assisted disease diagnosis models that include multi-modality data (different medical imaging modalities, free-text clinical notes and structured information), benchmark the models via multi-center external validations, and explore solutions to improve the downstream capability. The research will provide a foundation to advance ophthalmic disease diagnosis applications and a refinement